Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools: Equipment Supplement

PROJECT SUMMARY / ABSTRACT The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools supports studies in nonhuman primates that advance the genome editing field, and significantly contributes to the future translation of these technologies for the treatment of human disease. The Center brings together a robust team of multidisciplinary investigators with campus partnerships that capitalize on major strengths at UC Davis and offers state-of-the-art capabilities for Somatic Cell Genome Editing (SCGE) awardees to conduct high quality research in nonhuman primates.

Public health relevance
PROJECT NARRATIVE The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools serves the Somatic Cell Genome Editing Consortium by supporting studies in nonhuman primates that advance the field. Through these efforts the Nonhuman Primate Testing Center significantly contribute to the future translation of cutting-edge technologies for the treatment of a range of human diseases.